New Insights into the Biology of Exercise

ABSTRACT Support is requested for a Keystone Symposia conference entitled New Insights into the Biology of Exercise, organized by Drs. Sue Bodine, Bret H. Goodpaster and John P. Thyfault. The conference will be held in Keystone, Colorado from March 1-5, 2019. Exercise and regular physical activity are widely recognized to be important for maintaining overall health and wellness. Furthermore, exercise has been proven to be an effective therapy for the prevention and treatment of a variety of diseases including diabetes, obesity, cardiovascular disease, and cancer. The physiological response of selected tissues, such as skeletal muscle, heart, liver, adipose, and brain to exercise has been studied to varying degrees in healthy and unhealthy individuals; however, the cellular and molecular mechanisms underlying the acute responses and training adaptations to exercise remain poorly defined. The study of exercise is not a new field but is receiving increased interest because of the many health-promoting benefits of regular aerobic and resistance exercise. This conference includes selected speakers who can present new findings related to the response of multiple organs/tissues (skeletal muscle, liver, adipose tissue, heart, vascular, brain) to exercise in both animal models and humans. The overarching goals for the conference are to 1) encourage discussion of the integrative multiple organ response to exercise, 2) encourage discussion and integration of basic and translational research, and 3) provide an environment for investigators to network and initiate new collaborations.

Public health relevance
PROJECT NARRATIVE Exercise and regular physical activity are widely recognized to be important for maintaining overall health and wellness. This conference will occur at a time when there is great interest in exercise as both a means to maintain health throughout the lifespan, but also to prevent and treat chronic disease condition. In addition, this conference will promote an interdisciplinary exchange of ideas and assessment of where the exercise field is going; and explore how to best to move the field forward so that exercise research can have the biggest impact on improving human health.